Investigating the role of Alpha5Beta1 integrin in cognitive dysfunction

Title: Investigating the role of α5β1 integrin in cognitive dysfunction
Key words: eNOS, Vascular Dementia, α5β1 integrin, exercise, therapeutics
Abstract:
One common element between VaD and COVID-19 is the involvement of α5β1 integrin: a viable
receptor for SARS-CoV-2 and whose expression levels increase with age in the bilateral carotid
artery stenosis (BCAS) model of VaD. While the ability of SARS-CoV-2 to enter and alter brain
function is still being debated, VaD associated cognitive decline is better understood as a result
of chronic failure and disruption of the cerebrovasculature. As VaD is a progressive disease, of
which both physiology and symptoms worsen over time, the age-associated increase in α5β1
expression may be contributing to the ultimate development of cognitive dysfunction. Moreover,
if the binding of SARS-CoV-2 to α5β1 leads to overactivation or increase in expression of the
integrin, then COVID-19-associated cognitive decline may occur in a similar manner to that of
VaD. Exercise has been shown to improve VaD associated cognitive dysfunction, but the
mechanism and whether α5β1 integrin is involved is unknown. Thus, α5β1 integrin’s relationship
to cognitive decline and its potential to enhance exercise induced benefits through the following
project aims will be explored: using eNOS-deficient mice as a model of VaD, I will correlate
integrin α5β1 expression to age-related pathology (Aim 1) and determine if the combined
treatment of ATN-161 and exercise provides synergistic improvements to VaD outcome (Aim 2).

Public health relevance
PROJECT NARRATIVE The development of cognitive deficits seen in vascular dementia (VaD) and COVID-19 is poorly understood and lacks effective treatments. As both conditions have several overlapping factors, α5β1 integrin stands out as a key mechanistic variable. Here, we propose to investigate a novel mechanism by which increased expression of integrin α5β1, a receptor that we have implicated in both VaD and COVID-19, precedes cognitive decline and can act as a therapeutic target.